Combination Therapy of OvCA with Oligonucleotides and Photodynamic Therapy

? DESCRIPTION (provided by applicant): Drug resistance causes treatment failure and death in more than 90% of patients with metastatic cancer. Ovarian cancer (OvCa) is a leading cause of death from cancer in women with a projected 14,270 deaths in US in 2014, and it is generally diagnosed in advanced stages when the tumor has metastasized and numerous micrometastases with intrinsic or acquired resistance have formed. We aim to synchronize delivery of therapeutic oligonucleotides (ONs) and photodynamic therapy (PDT) agents to OvCa using nanoparticles (NPs), and thus to provide a combination therapy to overcome drug resistance in OvCa. ONs and PDT can provide mechanistically distinct therapy for resistant OvCa but both have limitations when used as monotherapy. ONs are capable of targeting any specific gene that causes drug resistance; however, their therapeutic activity had been constrained by the poor access to their intracellular sites of action because of non-productive endosomal trapping. PDT is a clinically approved anticancer procedure; however, it suffers from sub-lethal cancer cell killing due to a prosurvival autophagic mechanism and a short duration of action. We hypothesize that NP-based co- delivery enables complementation of these two modalities, leading to synergism at two levels. Firstly, when delivered together to endosomes in OvCa cells, laser-activated PDT effects trigger endosomal escape of ONs to their intracellular action sites. Thereafter, the functional delivery of the ONs can target specific genes and overcome drug resistance in multiple modes. Thus, when apoptosis-promoting Bcl-x splice-switching oligonucleotide (SSO) is used, it can guide PDT to a pro-death apoptotic pathway. When MDR1 siRNA is used, it can resensitize OvCa to paclitaxel, the first line chemotherapy drug to OvCa. We have prepared ultra-small integrin-targeted NPs carrying ONs and the PDT drug Ce6. Preliminary studies indicated that laser activation of Ce6 enables functional delivery of the ONs and causes cytotoxicity to OvCa cells. In this proposal, 4 specific aims are designed to test our hypothesis and realize the goal: 1. Elucidate cellular mechanisms for synergism of ONs and PDT and then optimize the NPs for greater synergistic action. 2. Evaluate therapeutic activity of the NPs in 3-D OvCa models that recapitulate some key features of in vivo microenvironment. 3. Evaluate anticancer activity of the NPs carrying Bcl-x SSO and Ce6 in vivo. 4. Test therapeutic activity of the NPs carrying MDR1 siRNA and Ce6. Studies proposed in this grant will thus provide distinct approaches to address the two underlying causes of drug resistance in OvCa: increased intrinsic survival ability and reduced intracellular drug concentration of OvCa cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: Successful implementation of this project will provide a highly specific cancer therapy due to receptor-targeted delivery, laser-guided activation, and cancer cell specific overexpression of oncogenes such as Bcl-x, all of which will contribute to a therapy with maximum cancer killing and minimum systemic toxicity. The targeted delivery systems can be easily changed to aim to other cancers by using different ligands, and we can target other genes causing drug resistance by choosing from various ONs including siRNAs, antisense, SSOs, microRNAs, and their antagomirs. Therefore, studies proposed in this grant will expand the physicians' menu of cancer therapies that can be customized for specific cancers, and increasingly, specific patients.